Flow Cytometry Shared Resource

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
FLOW CYTOMETRY SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The overall goal of the Flow Cytometry Shared Resource (FCSR) is to provide a broad array of advanced cell
analysis and isolation resources for a wide range of cancer-relevant studies carried out by basic and translational
scientists in the MECC. As a central component of its mission, the FCSR provides access to instrumentation and
expertise for analytical flow cytometry and fluorescence activated cell sorting. These resources are critical for a
large cohort of MECC scientists who use these technologies on a regular basis in their studies to explore the
biology of cancer and develop new therapeutics. Analytical flow cytometers housed in the FCSR include the
most advanced multispectral analyzers currently available (Cytek Aurora), with capabilities for rapid analysis of
>25 parameters per cell. A range of cell sorters are also provided, including cuvette type (FACSAria) and jet-in-
air type (MoFlow and Astrios) high speed sorters. FCSR has also recently acquired the most cutting edge, newly
developed multispectral cell sorter (ThermoFisher Bigfoot), which elevates the speed, accuracy and complexity
of cell sorting capabilities to unprecedented levels. In addition to its state-of-the-art core technologies in flow
cytometry, the FCSR has also expanded to incorporate several new related and complementary technology
platforms for immune monitoring of cancers in human subjects and animal models. These include the recent
acquisition of a multi-channel fluorescence slide scanning system (VectraPolaris), and equipment for gene
expression profiling at single cell and microscopic tissue levels (NanoString). FCSR provides technical expertise
and training to guide MECC investigators at all levels in the application of basic and advanced flow cytometry
and its other supported technologies. Services and training are supported by a full-time staff consisting of three
highly experienced research faculty level operations directors who carry out advanced technical procedures,
supervise training activities and manage the daily operations. There are also four experienced and highly trained
technicians who support equipment operation and maintenance. Ongoing review of new developments in areas
relevant to the FCSR by the senior faculty scientific director and faculty advisory group of the facility assures that
MECC investigators have access to the most advanced current and newly emerging technologies for cell
analysis and isolation. FCSR also organizes and supports seminars and demonstrations of new technologies to
ensure that MECC investigators are well informed about newly emerging applications of FACS and other related
technologies that can enhance their research. The technologies provided by FCSR are essential to the research
activities of MECC investigators and cannot be outsourced or obtained at other sites in any practical or cost-
effective way. FCSR serves as a critical component of MECC Shared Resources, and is a major pillar of support
for a wide range of cancer-focused basic and translational research.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward FLOW CYTOMETRY SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page